SURVEY COLLECTION AND ANALYSIS REGARDING COVID-19 DRIVEN DRINKING HABITS

The COVID-19 pandemic has created profound changes in a range of social, behavioral, and economic factors that are known to affect drinking behaviors, including incomes and employment, stress, opportunities for socializing, and alcohol availability. Simultaneous upheavals in these and other factors may create profound changes in drinking patterns and, in turn, the need for prevention and treatment services as well as health care for the wide range of alcohol-related health conditions. The National Institute on Alcohol Abuse and Alcoholism has a clear interest in monitoring and understanding these changes and their effects on public health. The purpose of this contract is to build on the findings of a previous survey in order to obtain insights into changes in alcohol consumption and closely related behaviors associated with the COVID-19 pandemic.